ROLE OF HOST AND VIRAL FACTORS IN RESISTANCE TO RABIES VIRUS INFECTION IN MICE

The principal goals/objectives of this project are six-fold: 1) to determine host and viral factors which control the resistance of inbred strains of mice to street rabies viruses 2) to determine if an animal model for persistent rabies virus infections can be established with the ultimate goal being to determine in which cells (s) virus is sequestered and whether it can be activated to induce disease and death 3) to understand the role of macrophages in rabies virus infections 4) to compare the protective capabilities of recombinant vaccines expressing different or multiple structural proteins of rabies virus 5) to understand the complex interaction between microglial cells, lymphocytes and cytokines in the pathogenesis of rabies virus infections and 6) to optimize DNA vaccines for the elicitation of neutralizing antibody and protection against lethal challenge of a global spectrum of rabies virus variants.